Efficient Delivery of Optimized Painless Nerve Growth Factors to the Central Nervous System to Treat Spinal Cord Injuries

Project Summary
The incidence rate for traumatic spinal cord injuries (SCIs) in the United States is estimated to be 54 cases
per million people or 17,900 new cases each year. SCIs have devastating consequences for the physical,
emotional, social, and vocational well-being of patients. The direct cost for the care of SCI patients is staggering
at $1.1-5.2 million per patient over their lifespan. Compared to civilian SCIs, SCIs in battlefield shows increased
severity and poorer neurological recovery. Delayed access to surgical spinal decompression and stabilization
after a SCI is the main cause for poor outcome. Therefore, treatments that can be used through systematic
injection, when surgical intervention is delayed, in order to limit the secondary injury and promote regeneration
is of urgent need. Advances in medical care of SCIs have taken place in the past two decades, however, effective
treatments are still limited. Pharmacological strategies, directly working on endogenous neurons, is highly
effective due to their neuroprotective and neuroregenerative capabilities. Nerve growth factor (NGF) is the first
discovered neurotrophin that plays a major role in the neural development of the central nervous system (CNS).
However, NGF is not currently available to patients due to its 1) poor penetration into the CNS, 2) limited duration
of bioavailability, and 3) enhanced nociceptor response.
To address these issues and provide an effective solution for SCI treatment, we propose to utilize a double-
encapsulation system to achieve effective delivery and controlled-release of painless NGF variant (NGFp), which
can preserve, protect, and regenerate the injured neurons to improve neurologic outcomes in spinal cord injuries
while dissipating pain. Specifically, we are applying a novel nanotechnology platform named “nanocapsules” to
effectively deliver NGFp into the spinal cord facilitated by choline transporters. Moreover, the double-
encapsulation system can entrap NGF nanocapsules within double emulsions to precisely control the release
kinetics of nanocapsules. Lastly, we will deliver NGFp, which has a reduced nociceptive response, but potent
neurotrophic and neuroprotective capability compared to wild-type NGF. Success of this project will provide an
effective treatment for SCI patients to improve neurologic outcomes and quality of life.

Public health relevance
Project Narrative Although nerve growth factor (NGF) is a promising pharmacological strategy to treat spinal cord injuries, its application is hindered by its large molecular size, high polarity, insufficient penetration into the spinal cord, and induced nociceptor response. These limitations have been corrected by validated technologies from each institution in this multi-disciplinary collaboration. In this proposal, the research consortium combine these technologies and synthesizes a novel double-encapsulation system, denoted as des-n(NGFp) and will test its therapeutic efficacy in a mouse spinal cord injury model.